Structure-guided protein evolution to develop improved natural ligand-based chimeric antigen receptor T cell therapy against CD70 in acute myeloid leukemia

Project Summary/Abstract
This project seeks to develop and optimize chimeric antigen receptor (CAR) T-cell therapies for acute myeloid
leukemia (AML). AML is the most prevalent acute leukemia in adults, yet has a dismal 5-year survival rate un-
der 30% with current standard-of-care therapies. Despite their well-documented efficacy in the treatment of other
hematologic malignancies, CAR-T therapies have shown limited efficacy in treating AML, highlighting the need
for additional innovative research in this area. The most well-studied AML CARs in development use single-chain
variable fragments (scFvs) to target CD33, CD123, or CLEC12A, resulting in severe toxicities in patients due to
their concurrent expression on hematopoietic stem and progenitor cells (HSPCs). Instead, this study proposes
to target CD70, a marker highly expressed on AML tumor cells and leukemic stem cells but not on HSPCs, using
a “natural ligand” CAR-T approach, based on CD70’s unique native receptor, CD27. This approach has shown
improved tumor cytotoxicity, CAR-T proliferation, and survival in preclinical models compared to scFv-based anti-
CD70 CAR-Ts. Given their superior safety profile, CD27-based CAR-Ts merit further optimization for efficacy.
Furthermore, there have been no comprehensive attempts to produce variants of natural ligand CARs with al-
tered binding affinity and, thus, potentially improved CAR-T efficacy. Therefore, I hypothesize that by employing
structure-based deep learning algorithms and high-throughput screening techniques, I can identify coding se-
quence alterations in CD27-based CARs that enhance their efficacy without increasing off-tumor toxicity.
In Specific Aim 1, I will evaluate the in vitro and in vivo efficacy of a set of CD27-variant CARs with computation-
ally predicted alterations in affinity to CD70. The phenotypic differences of these CD27-variant CARs, particularly
those influencing tumor cytotoxicity, will also be analyzed to elucidate the principles guiding natural ligand CAR-
T function. In Specific Aim 2, I will perform an in vivo competition assay of CAR-T proliferation to screen a large
library of CD27-variant CARs. The leading candidates will undergo further validation for tumor cytotoxicity, sur-
vival benefits, and CAR-T phenotypes, along with verification that the low off-tumor toxicity of the CD27-based
CAR is maintained. Successful execution of these aims is expected to yield superior CD27-based CAR designs
that would be beneficial in various AML scenarios and potentially other CD70-expressing malignancies, with the
long-term potential for translation to the clinic. Additionally, this natural ligand CAR development pipeline could
be extended to additional cancer antigens, signifying a broad therapeutic potential.
I will lead this project under the sponsorship of Dr. Arun Wiita, a physician scientist and expert in hematological
malignancies and cancer antigen identification, and the co-sponsorship of Dr. Justin Eyquem, an expert in CAR-
T development and CAR screening technologies. Completion of my research plan, alongside my comprehensive
training plan and robust mentorship from my research environment, will strongly equip me to become an inde-
pendent physician scientist focused on cancer immunology and immunotherapy research.

Public health relevance
Project Narrative Acute myeloid leukemia is the most common adulthood acute leukemia, with current patients suffering from a poor prognosis, high relapse rate, and extremely limited treatment options if standard chemotherapy and stem cell transplantation fail, as they do for the large majority of patients within 5 years. There are currently no cellular immunotherapies approved for AML despite their success in other hematological malignancies, highlighting a clear potential and need for novel CAR-T strategies to improve health and survival outcomes in AML patients. This project represents an innovative approach to developing improved CAR T-cells against AML, with the potential to improve survival outcomes and reduce morbidity in a significant proportion of AML patients, while also developing a pipeline that could be utilized for the development of additional CAR therapies compatible with natural ligand-based receptors.